Investigating how nuclear pore components exploit an ER-dependent quality control pathway

Project Summary
N/A – this section is not applicable.

Public health relevance
Project Narrative N/A – this section is not applicable.